Investigation into the role of value learning in core features of autism in toddlers

ABSTRACT.
Limited selective social attention represents one of the best-replicated biomarkers in ASD. The
mechanisms underlying differences in social attention in ASD remain to be identified. One of the mechanisms
that contributes to attentional selection in neurotypical individuals is value learning. Value learning represents
an implicit (i.e., occurring outside conscious awareness) process through which initially neutral stimuli (e.g., a
face) when paired with a reinforcer (e.g., the face smiling) gains enhanced capacity to attract attention, or
value-based salience. Our group has demonstrated that compared to typically developing and
developmentally delayed children, preschoolers with ASD exhibit attenuated value learning when both stimuli
and reinforcers are social (face, smiling face) and enhanced value learning when both stimuli and reinforcers
are nonsocial (fractal, evolving fractal). If present early in life, this type of imbalance in propensity to learn
about social and nonsocial stimuli may alter the experience-dependent development of neural circuitry
supporting salience detection and learning and contribute to atypical development in ASD. Despite their
potential importance for development of selective attention and cognition, the factors contributing to differences
in value learning in ASD are not fully understood. Specifically, it is not clear if altered value learning results
from children having trouble making associations between stimuli and reinforcers (value learning) whenever
the stimuli are social (or nonsocial) in nature (stimulus effect) or whenever the reinforcers are social (or
nonsocial) in nature (reinforcer effect) or when the stimulus and reinforcer type conspire together to give rise to
specific patterns of value-based attentional biases. In the present proposal we plan to carefully manipulate the
type of stimuli and reinforcers and consider key cognitive, affective, and biological covariates, to elucidate the
processes through which initially neutral social and nonsocial stimuli gain privileged status in the attentional
system in toddlers with and without autism. We also plan to investigate how individual differences in this value
learning associate with core attentional and behavioral features of autism. The project will examine value
learning in 18- to 30-month-old toddlers with ASD (n=100), typical development (TD) (n=50), and
developmental delays (DD) (n=50) matched for chronological age and sex using a gaze-contingent eye-
tracking implicit value learning task developed in our lab. To test our predictions, in Aim 1, effects of stimulus
(social versus nonsocial) and reinforcer (social versus nonsocial) on indices of value learning will be examined
in ASD, TD, and DD groups. In Aim 2, we will examine the associations between value learning indices and
selective social attention measured using both a validated free-viewing screen-based (2a) and a novel live eye-
tracking (2b-exploratory) task. In Aim 3, we will examine concurrent (18-30 months) and prospective (36
months) associations between indices of value learning (Aim 1) and selective social attention (Aim 2) and
measures of severity of autism symptoms in the social and repetitive behavior domains.

Public health relevance
NARRATIVE. The proposal aims to investigate the role of stimulus and reinforcer type (social versus nonsocial) in value learning and to reveal if autism-specific alterations in value leaning are present at the earliest time when autism can be reliably diagnosed, and if the individual differences in value learning associate with core attentional and behavioral features of autism. If present early in life, differences in value learning in the social and nonsocial domains may have a profound impact on the experience-dependent development of neural circuitry supporting selective attention and on development of social cognition.